Social Engagement and Well-Being in the Final Five Years of Life

PROJECT SUMMARY/ABSTRACT
The objectives of this proposal are to: (A) identify how patterns of social engagement change in the final five
years of life, and (B) explore the roles of these changes in shaping well-being and quality-of-life in the years
prior to death, as well as end-of-life health care quality, among the older adult population in the United States.
Social engagement is a well-established determinant of health, well-being, and mortality, and includes both
interaction with close, intimate social ties as well as broader participation in social activities. Prior research
demonstrates that patterns of social engagement change throughout later life in response to changes in health
and other life course transitions. However, these patterns are relatively understudied during the final years of
life, when cognitive and physical health declines may limit social engagement, and yet, when well-being may
especially benefit from social engagement. To accomplish these objectives, we will draw on secondary survey
data from the National Health and Aging Trends Study (NHATS), an annual, nationally-representative
longitudinal study of Medicare recipients. First, we will use growth curve models to accomplish our aim of
estimating how personal social networks and participation in various social activities (e.g., volunteering,
organized group activities) each change during the final five years of life. Second, we will use multiple
regression and cross-lagged panel models to accomplish our aim of identifying how various forms of social
engagement are associated with quality of life in the five years prior to death. Our focus on quality of life will
include healthcare in the last month of life, and physical function, cognitive function, and psychological
well-being in the five years prior to death. We will pay particular attention to how changes in social engagement
vary across older adults with and without dementia and physical functional impairment, for whom social
engagement may be particularly difficult to maintain, but for whom maintaining high levels of social
engagement might greatly benefit end-of-life experiences. We expect that the findings from this study will
inform the potential for social interventions to enhance quality of life at the end of the life course, as a
particularly vulnerable period for both health and social well-being. The number of older adults in the United
States who will die with dementia is projected to more than double in the next three decades, highlighting the
urgent need to understand the social contexts of end-of-life experiences that are unique to this population. As
the United States ranks below many peer countries in quality of end-of-life care, this proposal will draw much
needed attention to social factors outside of the healthcare system that may be considered in efforts to improve
end-of-life experiences for older adults, their family members, and their care providers.

Public health relevance
PROJECT NARRATIVE This study holds significant implications for public health given its focus on social engagement as a potential pathway for improving end-of-life outcomes for older adults, including those with dementia. The study will investigate changes in social engagement and its role in shaping quality of life in the final years of life and end-of-life experiences. These findings will guide interventions to enhance later-life social engagement as a pathway to improve quality of life in the years before death, in ways that reduce burdens on family members, caregivers, and the healthcare system.